Molecular mechanisms underlying trachea formation and the pathology of tracheomalacia and complete tracheal rings

Tracheobronchomalacia (TBM) and Complete Tracheal Rings (CTR), are congenital conditions characterized by
abnormal tracheal cartilage and muscle and associated with high morbidity and mortality. The etiologies of TBM
and CTR are poorly understood, and current interventions are limited to invasive surgery and palliative care. The
overarching goal of the present application is to define underlying molecular mechanisms of congenital diseases
affecting trachea development. Our published studies demonstrated a critical role for respiratory endoderm in
determining the dorsal-ventral organization of the tracheal mesenchyme where cartilage and smooth muscle
developed. Endodermal deletion of Wls (Wntless), a cargo receptor necessary for secretion of Wnt ligands,
results in lack of tracheal cartilage that is replaced by abnormally organized smooth muscle, resembling TBM
pathology. Our RNA Sequencing analysis identified Notum, and Bmp4, as candidate Wnt target genes in tracheal
mesenchyme that regulate cartilage and trachealis smooth muscle formation downstream of epithelial Wls-
induced signaling. We hypothesize that Notum acts by suppressing canonical Wnt signaling while
simultaneously promoting non-canonical Wnt and BMP signaling required for tracheal mesenchyme
differentiation. Thus, Notum is at the core of a novel model of regulation for the output of Wnt signaling wherein
epithelial Wnt ligands first promote Wnt/b-catenin signaling and then turn it off to allow for non-canonical Wnt
activity. To test the central hypothesis, we will: SA1: To determine the mechanism by which Notum promotes
tracheal cartilage formation. Using novel mouse model and ex vivo studies, we will determine the extent to which
deletion or overexpression of Notum affects Wnt/b-catenin dependent and independent signaling activity, and
the epistasis among Notum, Wnt5a, and Wnt-b-catenin to pattern cartilage. SA2: To define the mechanism by
which Bmp4 and Wnt signaling interact to mediate cell fate of tracheal mesenchyme. Performing in vivo and ex
vivo studies we will determine whether Wnt/b- catenin synergizes with BMP to promote cartilage by inducing
Notum and Wnt5a/Ror2 expression; and whether Notum and Bmp4 cooperate to repress ectopic muscle in
ventral tracheal mesenchyme. SA3: To test the hypothesis that epithelial Wnt signaling directs cytoskeletal
organization of trachealis smooth muscle. We will examine whether 1) canonical Wnt ligands from the epithelia
act directly to promote myoblast cytoskeletal organization by regulating myogenic gene expression; 2) epithelial
Wnt ligands activate non-canonical mesenchymal Wnt signaling working via Ror2 to mediate myoblast
cytoskeletal organization. The proposed studies will identify critical molecular signaling pathways that mediate
tracheal morphogenesis and will shed light on the pathology of TBM and CTR. Thus, these studies will lay the
foundation for better diagnosis and therapeutic management of congenital and structural defects of the trachea.
!

Public health relevance
Tracheomalacia, complete tracheal rings, and other structural defects of the windpipe are prevalent conditions associated with high morbidity and for which the current treatments are just supportive, or highly invasive. Understanding the molecular and cellular causes of these diseases will allow for better diagnosis and less invasive and more efficient treatments. The goal of this proposal is to identify the biological molecules mediating the normal formation of the cartilage and muscle of the trachea and how these molecules relate to diseases affecting the trachea.!